Defining the Cellular Morphogenic Behaviors that Shape the Developing Heart

PROJECT SUMMARY
Congenital heart defects (CHDs) are among the most prevalent and devastating congenital disorders, occurring
in nearly 1% of live births and creating live-changing complications for affected individuals. The origins of CHDs
lie early in embryogenesis as the heart takes shape. Previous studies have demonstrated that the earliest cardiac
progenitor cells are specified during gastrulation, and then migrate to the anterior of the embryo to form the
transient cardiac crescent and subsequent linear heart tube. Thereafter, the heart tube undergoes right-ward
looping to properly position the segments of the heart tube and produce the four-chambered adult heart. Although
the gross morphological processes that facilitate heart development have been described, the specific cellular
behaviors that drive these processes remain unknown.
The primary objective of this proposed work is to precisely define the cellular morphogenic behaviors, and their
genomic determinants, that shape the developing heart in order to better understand how CHDs arise when
these behaviors are mis-regulated. This will be achieved through three specific aims: i) Defining the cellular
morphogenic behaviors that underlie heart tube formation by conducting live imaging of cardiac progenitors
during cardiogenesis in mouse embryos; ii) Determining the role of key cardiac transcription factors Tbx5 and
Mef2c in heart tube morphogenesis by quantifying disrupted cellular behaviors en route to improper heart tube
formation in mutant embryos; iii) Identifying the genomic determinants of heart tube morphogenesis by
performing multiomic analysis of gene expression and chromatin accessibility for wild type, Tbx5-null, and Mef2c-
null embryos. This postdoctoral training will be conducted under the supervision of Dr. Benoit Bruneau, a leader
in the fields of cardiac biology and embryology, at Gladstone Institutes, a world-renowned research center with
an outstanding commitment to the career development of its trainees. The Bruneau laboratory and the Gladstone
core facilities will provide all the necessary resources and expertise required to enable successful completion of
the proposed work. The combination of high-resolution live embryo imaging and single cell genomic analysis will
identify both the physical processes that are required to build the heart, as well as the transcriptional programs
that spatiotemporally regulate those cellular behaviors. This information will advance our understanding of
mammalian cardiogenesis beyond the current single-gene paradigm, and will provide important insights to inform
how CHDs arise during embryogenesis.

Public health relevance
PROJECT NARRATIVE Congenital heart defects (CHDs) affect nearly 1% of live births and arise early in development as the heart takes shape; yet, the precise cellular morphogenic behaviors that shape the developing heart remain unknown. This proposal aims to use live embryo imaging and multiomic analysis of gene expression and chromatin accessibility to define these critical cellular behaviors and their genomic determinants. These studies will advance our fundamental knowledge of cardiogenesis and help to inform the origins of CHDs.